The impact of the commensal vaginal microbiome on resident memory T cell differentiation and function

Project Summary
Every day, there are more than 1 million new cases of sexually transmitted infections (STIs) worldwide that can
have long-term health consequences, including infertility and pregnancy complications. For women, the vaginal
microbiome has emerged as an important factor in STI acquisition and recurrence, but the mechanisms by which
the microbiome influences this process is not well understood. Bacterial vaginosis (BV) occurs when the vaginal
microbiome becomes dysregulated and imbalanced due to an overgrowth of anaerobes. Among women below
the age of 50, this is one of the most common vaginal conditions that increases susceptibility to reproductive
tract infections. Studies on how these anaerobes interact with the local immune system have mostly been
focused on innate immune cells. BV-associated bacteria’s impact on CD8 T cell mediated responses and
resident memory T cell differentiation and function remain unexplored. My long-term goal is to determine the role
of commensal and dysbiotic bacteria on CD8 tissue resident memory T (TRM) cell immunity within the female
reproductive tract (FRT). Previous studies on BV and innate immune cells have shown that bacterial metabolites
from BV-associated bacteria lead to a state of chronic inflammation, partially mediated by their actions on local
epithelium and the release of damage-associated cytokines. Based on this, I hypothesize that the inflammatory
cytokines produced by these anaerobic bacteria will alter the differentiation of TRMs and enhance their pro-
inflammatory function. To test this hypothesis, I will use a combination of in vitro and in vivo models mimicking
human BV in mice to characterize the tripartite interaction between the microbiome, the vaginal epithelium, and
CD8 TRMs. In aim-1, I will evaluate the impact of vaginal microbial metabolites on CD8 T cell function using a
novel vaginal epithelial organoid (VEO) and T cell co-culture system. In aim-2, I will test the contribution of these
vaginal microbial metabolites in vivo via either metabolite supplementation or direct engraftment of bacteria into
the FRT of mice. Understanding CD8 TRM interactions with the vaginal microbiome will be instrumental in
developing therapies to reduce STI transmission and pregnancy complications and improve overall reproductive
health. In preparation for this proposed work, my training is being overseen by my mentor Dr. Beura, who takes
an active role in developing my immunological techniques, critical thinking skills, and independent
experimentation through regular one-on-one meetings. I am also supported by my co-sponsor, Dr. Laurent
Brossay, and the oversight of the Brown University Pathobiology training program allowing me plentiful
opportunities to engage the scientific community and broader public to improve my scientific communication
skills. Completion of this proposal will equip me with the necessary attributes and key foundational knowledge
to pursue a successful career as an independent researcher in the field of viral infection and immunology.

Public health relevance
Project Narrative This project will reveal new interactions between the vaginal microbiome and the adaptive immune response, specifically regarding CD8 tissue resident memory T (TRM) cells that are instrumental in controlling and eliminating pathogenic infections. Utilizing anaerobic bacteria common to bacterial vaginosis (BV), a vaginal condition that affects many women and leads to negative downstream health consequences such as heightened susceptibility to sexually transmitted infections and preterm birth, the impact of BV on CD8 TRM differentiation, function, and homeostasis will be investigated. The objectives of this proposal are as follows: 1) evaluate the CD8 TRM transcriptional and functional changes in response to commensal and dysbiotic bacterial metabolites and the cytokines produced and 2) test the in vivo consequences of these bacteria and metabolites on CD8 TRMs in a murine model of BV.